ORS-ISFR 17th International Biennial Meeting

PROJECT SUMMARY
Bone fractures occur in more than 25 million Americans per year, and a significant percentage of those fractures
fail to heal. Fractures that show delayed or failed progression to heal account for the majority of patient disability
and costs. Thus, there is an urgent need to better understand the biology of bone healing, and to use that
knowledge to develop new diagnostics and therapeutics. We are seeking support for the 17th Biennial conference
of the International Section of Fracture Repair (ISFR). In 2017, the ISFR was incorporated as a section within
the Orthopaedic Research Society (ORS), thereby leveraging the outreach of the largest scientific organization
in the world dedicated to orthopaedic research. The ISFR is dedicated to the advancement and exchange of the
most current scientific ideas and research findings on fracture repair and its application to the improvement of
patient care. Our mission is be the premier forum to integrate and present cutting-edge ideas related to clinical,
translational, and basic science research of fracture healing. With an organizational theme of “Transdisciplinary
Science”, sessions will focus on the newest understanding of mechanobiology from the cellular to patient scale
and its role in bone repair; commercial considerations for device development and translating ideas from bench
to market; and personalized regenerative therapies and associated advanced technologies (i.e., therapeutics,
organ-on-a-chip, interplay with the immune system). In an effort to increase clinical participation, the Biennial
ISFR Meeting will be held just prior to the International Combined Orthopaedic Research Societies (ICORS) 30th
Anniversary World Congress. The ICORS World Congress program is co-hosted by the European ORS (EORS),
British ORS (BORS), and AO Research Institute Davos. To catalyze cross-pollination between the ISFR and
these societies, the second day of our meeting (September 7th) has been designed as a clinical bridge day where
both ISFR and ICORS members can attend. In total, we will have 2 invited keynote speakers, 20 invited session
speakers, and 15 abstract-selected podium presentations. We anticipate an additional 30-40 abstracts selected
as posters. The meeting will present the most up to date research on fracture healing basic biology, translational
research, and prospective clinical studies. The Program Committee is highly focused on fostering an inclusive
environment. Surgeons, biologists, engineers, and policy makers will attend the meeting and be drawn from
academia, government, and industry. A variety of activities will be focused on career development and
networking for trainees in the bone healing field.

Public health relevance
NARRATIVE The 17th Biennial Conference of the ORS/ISFR titled “Transdisciplinary Science to Solve Unmet Needs in Fracture Repair” will be held in September 2022. The goal of the event is to foster growth and innovation in the field of fracture repair with an emphasis on the synergy and cooperation between basic scientists and clinicians. Researchers, clinicians, industry partners, policy makers, postdoctoral fellows, and graduate students will attend the meeting to discuss the most pressing questions in the field of fracture repair and to consider bold approaches to solving those problems.